Personalized cancer drug repurposing using single cell RNA-Seq data

Abstract
Human cancers are highly heterogeneous. Studying tumor and tumor-microenvironment (TME), particularly
those that are likely to develop resistance, is essential for the effective development of personalized anti-cancer
therapy. In recent years the development of new single-cell genomics technologies, such as single-cell RNA-
Seq (scRNA-Seq), has made this analysis possible at the single-cell level. Drug repurposing is an effective
strategy for identifying and developing new uses of drugs outside the scope of their original medical application.
This strategy offers various advantages over developing an entirely new drug for cancer therapeutics, such as
the lower risk of failure, significantly shorter time frame for drug development, and much less cost. The “reverse
matching” approach to search for drugs from large pharmacogenomics databases such as the LINCS L1000
system has been shown as an effective approach to apply to the genomics data. However, conventional
computational methods using the reverse matching principle have been relying on bulk samples, overlooking the
complexity of the tumor ecosystem. To fill in the gap, we have recently developed a comprehensive drug
repositioning computational framework called ASGARD (version 1.0), which utilizes the single cell RNA-Seq
(scRNA-Seq) transcriptomics data as the input. In this project, we will improve ASGARD version 1.0 to the next
version, by fully exploiting the features related to tumorigenesis. We will consider genetic information, in addition
to gene expression from scRNA-Seq data; we will also include interactions between tumor cells and TME cells
to formulate the new and improved drug scores, for drug ranking. After benchmarking, we will apply ASGARD
version 2.0 to repurpose drugs for primary liver cancers. We will validate these drug candidates using a
combination of literature evidence, in vitro experiments and electronic medical record (EMR) data.

Public health relevance
Project Narrative Single-cell transcriptomics is a popular new genomics technology, but its applications to help clinical treatment decision are lacking. In this project, we aim to improve ASGARD, a single cell RNA-Seq based computational method for predicting drug reposition, by considering new mechanisms for cluster matching and interactions between cell types. We will use the new ASGARD version 2.0 to predict drugs in liver cancer.